Advancing the small molecule drug candidate with dual specificity as a therapy for dry AMD

Age-related macular degeneration (AMD) is the predominant cause of blindness in the United States.
Lipofuscin accumulation in the retina, which increases with age, is implicated in the pathogenesis of dry AMD.
Pyridinium bisretinoids constitute the primary cytotoxic elements of retinal lipofuscin. Inhibiting bisretinoid
synthesis is a viable approach for treating dry AMD. The synthesis of bisretinoids is driven by the traffic of
retinol from the bloodstream to the retina. The RBP4-Transthyretin (TTR) complex acts as the primary carrier
for delivering retinol to the eye. RBP4 antagonists displace retinol from RBP4, causing the RBP4-Transthyretin
(TTR) complex to dissociate. This reduces retinol transport to the eye and suppresses lipofuscin bisretinoid
synthesis in the retina. Fenretinide, a first-generation RBP4 antagonist, suppressed the expansion of atrophic
lesions in dry AMD patients when serum RBP4 levels fell below the 1-micromolar threshold. However,
selective RBP4 antagonists, by disrupting the RBP4-TTR interaction, could potentially destabilize wild-type
TTR tetramers promoting TTR aggregation in individuals with age-related predisposition to TTR amyloidosis
disease. We have recently introduced a novel class of bispecific RBP4/TTR ligands. These compounds not
only reduce serum RBP4 levels and suppress bisretinoid synthesis but also bind to the thyroxine binding sites
on TTR. This binding stabilizes TTR tetramers and prevents the formation of TTR amyloids. (R)-ACPHS-62, an
optimized bispecific RBP4/TTR ligand, emerged as a drug candidate for treatment of dry AMD in individuals
with age-related predisposition to TTR amyloidosis. The proposed project has two main objectives: first, to
perform experiments required to progress (R)-ACPHS-62 towards GLP-compliant IND-enabling studies (Aim 1;
R61 phase); and second, to carry out GLP-compliant IND-enabling studies and submit the IND application
(Aim 2; R33 phase).

Public health relevance
Dry age-related macular degeneration (AMD) is the leading cause of blindness in the United States. The available treatment options for dry AMD are limited. The core objective of the proposed study is to advance safe and effective new therapies for addressing this condition.